Administrative Core

Summary: The objective of the Administrative Core (Core A) is to provide the administrative support for the efficient functioning of the program project. The PI, Dr. Asrar Malik, will be responsible for evaluating the progress of the program project as a whole and of the individual research projects. The Administrative Core will coordinate the inter-project collaborators and develop new arrangements as deemed necessary for the scientific progress of the program. The Administrative Core will also provide the projects and cores with a monthly review of all expenditures and will deal with University Accounting and Grants offices concerning grant budgets. The Administrative Core will also be responsible for the completion of all annual Progress Reports for the program project sent to the NIH. Additionally, the administrative support provided by the Administrative Core will reconcile all budgets of the projects and cores.. The Administrative Core will also be responsible for organizing various weekly research meetings and seminars as well as meetings of the members of the Internal and External Advisory Committees invited to visit the program (outiined in the Introduction of the grant). The Administrative Core will be used equally by the four projects.